GNRH AGONIST STIMULATION DIAGNOSTIC

We will investigate whether responses to the GnRH agonist nafarelin distinguish among children with various disorders of gonadal function. Specific hypotheses will be tested to determine whether changes in serum concentrations of LH, FSH, estradiol, testosterone, and biosynthetic intermediates after 1 injection of nafarelin can be used to distinguish among different categories by independent tests.